Multi-organ protection from hyperoxia of the severely premature infant

Abstract
The broad, long-term objective of this proposal is to develop a safe method of protecting retinal
blood vessels from oxygen induced toxicity that accompanies premature birth. Oxygen therapy is
necessary to prevent mortality in these infants but is harmful to premature retinal tissue. Oxygen
toxicity to the premature retina, known as retinopathy of prematurity (ROP), blinds 150,000-
200,000 children worldwide annually. Quantitative analysis of retinal and lung vasculature in
mouse and rat models of human ROP demonstrate that preservation of hypoxia inducible factor
(HIF) activity through HIF prolyl hydroxylase domain protein (PHD) inhibition (HIF PHi) safely
prevents oxygen-induced lung disease, hypomyelination of the central nervous system, and
retinopathy (OIR). We have definitively demonstrated that our systemic strategy of PHD inhibition
requires liver specific HIF-1α activation. Our studies have demonstrated that the fetal liver uses
HIF induced 1C metabolism (1CM) to protect distal capillary beds from oxygen induced growth
suppression. These findings make liver specific HIF PHi a unified approach to preventing ROP
by biochemically addressing both hyperoxia of prematurity (by stabilizing HIF in hyperoxia) and
separation from the maternal circulation (by stimulating the liver to upregulate protective metabolic
pathways). The specific goal of this application is to enable the premature infant to benefit from
oxygen supplementation (reducing mortality) by creating a liver specific small molecule to
stimulate the oxygen sensor in the severely premature infant to protect it from excess oxygen.
Results from these studies will create a therapy to protect severely premature infants and
eradicate retinopathy of prematurity while developing a strategy that might revascularize ischemic
tissues.

Public health relevance
Project Narrative High blood oxygen concentrations are required to keep premature infants alive but harm developing blood vessels in the premature retina to cause the most common form of childhood blindness known as retinopathy of prematurity (ROP). Stabilization of hypoxia inducible factor (HIF) can promote blood vessel protection even in high oxygen to prevent many disorders of prematurity caused by oxygen such as ROP, lung disease, and brain injury. This project will develop translatable small molecules to protect the retina, the lung, and the brain from oxygen induced injury to develop this strategy as a therapy for premature infants.